Central Mechanisms Modulating Visceral Sensitivity

OBJECTIVES OF THE PROJECT: This resubmission of a VA Merit grant renewal continuously funded
since 2005 focusing on understanding the basic mechanisms that underlie chronic pain and translating those
findings into new therapeutic options for both male and female Veterans. This is important as current
therapeutic approaches for treating our Veterans with chronic pain are largely ineffective due to a paucity of
understanding of the mechanisms leading to chronic pain.
RESEARCH PLAN & METHODOLOGY: This renewal application will build upon the novel findings from
the parent grant and also takes advantage of cutting edge discovery approaches to delineate neural pathways
and molecular mechanisms leading to stress-induced chronic pain. There is evidence of increased pain
reporting in female veterans, thus specific Aim 1 will utilize state of the art approaches to test the hypothesis
that sexually dimorphic epigenetic dysregulation in the central nucleus of the amygdala (CeA) underlies gene
expression changes mediating the persistent effects of stress on visceral nociceptive processing. Under Specific
Aim 2 we will take advantage of clinical evidence suggesting that chronic pain in patients can be reduced by
psychological therapies such as biofeedback, relaxation training and yoga; however, the mechanisms by which
such psychotherapies improve clinical pain are unknown. We will build upon our preliminary data showing the
therapeutic potential of environmental enrichment to reverse stress-induced visceral pain by restoring
corticotropin-releasing hormone (CRH), GR and mineralocorticoid receptor (MR) expression in the CeA. This
aim will also investigate whether epigenetic mechanisms in the CeA underlie the effects of EE on chronic
stress-induced visceral pain.
ANTICIPATED OUTCOMES: In this application, we propose an approach that offers a novel way of
thinking about chronic pain by using state of the art epigenetic techniques combined with classical behavioral
outcome measures to identify mechanisms that will enhance our basic understanding of chronic pain. Under
Specific Aim 1 we anticipate that there are unique central mechanisms driving female vulnerability for pain. We
expect to show that heightened pain following chronic adult stress is modulated through epigenetically
mediated mechanisms within the CeA, and that there will be significant differences between males and females.
Under Specific Aim 2 we anticipate reversing the abnormal molecular events occurring within the CeA in
response to chronic stress using environmental enrichment and investigate the importance of histone
modifications to mediate the effects of environmental enrichment.
RELEVANCE TO VETERANS HEALTH: Taken together the work proposed in this VA Merit grant will
substantially advance our understanding of the neural and molecular level events responsible for chronic pain
and taken together with our previous data provide a unifying central hypothesis for how stress leads to chronic
pain. The VA provides specialized health care for veterans with chronic pain, however therapeutic options for
pain relief are very limited and fraught with side effects. Scientifically, the results from this project will identify
a novel stress-associated brain circuit, along with the specific neurotransmitters, that modulates chronic pain.
Identification of the mechanisms and circuitry involved in chronic stress-induced pain could lead to new
targets for therapies to treat veterans experiencing chronic pain, which is a significant unmet healthcare
burden. Furthermore, since female veterans with anxiety-related disorders have higher rates of pain, our
research will compare data from male and female rats in an attempt to identify novel mechanisms that may be
unique to female veterans.

Public health relevance
This renewal of a VA Merit grant continues to focus on understanding the basic mechanisms that underlie stress-induced chronic pain. This proposal is highly relevant to the patient-care mission of the Department of Veterans Affairs, since the VA cares for a Veteran population that has been exposed to severe stress during deployment. Furthermore, a fundamental concern in the VA Health Care system is the paucity of therapies to treat military service members and Veterans with chronic pain. It is our overarching hypothesis that neuroplastic changes within amygdala lead to stress-induced chronic pain. If our hypothesis is proven correct, our results will enhance understanding of the mechanisms by which stress alters behavior to worsen and prolong pain disorders. Importantly our findings may identify novel approaches and targets for new therapies directed at the brain to improve the treatment or even reduce the risk for the development of chronic pain in Veterans.